Advancing Native Mass Spectrometry Analysis with Easier, Faster and More Accurate Intact Mass Deconvolution for Proteins and Nucleic Acids

PROJECT SUMMARY / ABSTRACT
This research proposal aims to advance the field of native mass spectrometry (MS) analysis by developing an
innovative intact mass deconvolution method designed to significantly improve the speed, accuracy, and user-
friendliness of proteins and nucleic acid molecular weight determination. Despite the pivotal role of MS in
pharmaceutical research and biopharmaceutical applications, existing challenges such as data artifacts, slow
processing speeds, and the complexity of spectral analysis tools hinder its full potential. Our project is organized
into three primary aims: 1) To implement enhanced deconvolution techniques that reduce artifacts and optimize
processing speed without sacrificing accuracy; 2) To automate spectrum reconstruction for efficient handling of
diverse analytical needs; and 3) To conduct a comprehensive performance evaluation of our method against
current leading technologies. Through these efforts, we anticipate addressing critical gaps in MS analysis and
facilitating deeper insights into the molecular mechanisms underlying health and disease. The outcome of this
research promises to redefine the capabilities of mass spectrometry in modern biomedical research, offering a
powerful tool for the scientific community to unravel the complexities of biological molecules.

Public health relevance
PROJECT NARRATIVE This project will develop a new way to analyze the mass spectra of large biomolecules quickly, accurately, and easily. This involves creating smart algorithms that can more efficiently and accurately determine the molecular weight of molecules and allow for automating the process to save time and accelerate the drug discovery and approval pipeline.